Preclinical Assessment of a Compliance Matched Biopolymer Vascular Graft - Diversity Supplement

PROJECT ABSTRACT
Cardiovascular diseases (CVDs) stand as the primary contributor to global mortality and play a significant role
in diminishing the quality of life. The growing incidence of cardiovascular diseases has led to an escalating
demand for cardiac bypass grafting (CABG), now recognized as the most prevalent cardiac surgical procedure
on a global scale. Despite autologous tissue interventions in CABG being considered among the most effective
treatment options, their failure rate remains as high as 42.8%, with only 50% to 60% maintaining patency after
a decade. Vascular engineering research has aimed to create tissue-engineered vascular grafts (TEVGs) in the
form of acellular or cellularized constructs as an alternative solution. Despite decades of research progress, only
a limited number of TEVGs have progressed to clinical studies, and currently, there are no clinically approved
TEVGs in use.
Aim 1: Quantify VSMC infiltration in compliance matched TEVGs biofabricated with mesoscopic porosity
features in-vivo. First, we will test the hypothesis that the manufactured mesoscopic porosity features can influ-
ence the rates of cellular migration and proliferation of native vascular tissue onto a tissue-engineered vascular
graft (TEVG). In this Aim, we will employ two-photon subtractive manufacturing to enhance cell infiltration in our
compliance-matched TEVGs in vivo. This technology will create precisely cut pores to enhance cell infiltration.
The rationale behind this approach is rooted in the notion that heightened porosity will facilitate greater infiltration
of vascular smooth muscle cells (VSMCs), thereby promoting enhanced engraftment and bolstering the produc-
tion of extracellular matrix (ECM). By optimizing the porosity, we aim to create an environment conducive to robust
cellular integration and ECM synthesis within the TEVGs.Cellular migration and proliferation will be evaluated at
the end of a 4 week time period.
Aim 2: Quantify the hemocompatibility of SB coated compliance matched TEVGs in-vivo. Secondly, we will
evaluate the efficacy of SB coating in reducing platelet deposition on our TEVGs in-vivo. We aim to investigate
whether SB-coated TEVGs will reduce platelet deposition on the graft surface and enhance in vivo hemody-
namics. Additionally, we will conduct comprehensive characterization of the resulting polymers, examining their
mechanical and thermal properties, hydrophilicity, biodegradability, and thrombogenicity. The rationale behind
this Aim lies in the hydrophilic nature of the SB coating, which is expected to mitigate thrombotic deposition both
before and after significant degradation. This assessment aims to provide insights into the long-term performance
and biocompatibility of the SB-coated TEVGs.

Public health relevance
PROJECT NARRATIVE Nearly 400,000 coronary artery bypass grafts (CABG) are performed each year making it the most commonly performed major surgical procedure. Even though autologous tissue interventions in CABG procedures are regarded as some of the most effective treatment options, their failure rate remains notably high. This proposal aims to employ two-photon subtractive manufacturing and sulfobetaine (SB) coating to investigate the impact of porosity on the biomechanical responsiveness of the TEVG, reduce thrombotic deposition, as well as to examine the growth and proliferation of native cells within the graft.